Concentration and single virion analysis of the virome

ABSTRACT
Clinical virology is predicated on the workflow of analyzing small sample volumes (to minimize patient discomfort,
storage, and fit legacy infrastructure) for a single analyte, i.e., virus, with utmost precision. The human virome
project (HVP) does not share these restrictions. The HVP priority tissues of urine, stool, saliva, and blood can
be acquired from healthy people in a 50 – 500 ml sample size. For instance, the Red Cross makes normal
plasma available in 500 ml bags, and NGS allows for the characterization of all human viruses in a single
reaction. This proposal responds to RFA-RM-23-018 with the development of two novel tools: AIM 1, a virus
purification pipeline that utilizes larger volumes to achieve < 1 genome copy/ ml sensitivity; AIM 2, a single virion
detection pipeline to provide an accurate denominator of how many intact virions a given NGS sequence set is
representing. We hypothesize that Viral Direct Counts (VDC) akin to bacterial direct counts will become the
essential parameter for integrating the studies in the HVP.

Public health relevance
NARRATIVE Clinical virology differs from human virome project (HVP) and requires new tools. This proposal responds to RFA-RM-23-018 with the development of two novel tools: a better virus purification pipeline and AIM 2, a single virion detection method to measure of how many virus particles are in a sample.